Metabolic implications of radiation response in oligometastatic prostate cancer.

Altered metabolism in cancer cells is recognized as a hallmark of malignant transformation and has been
shown to be in part responsible for metastatic spread due to its role in the fate of anchoring metastases to the
tumor microenvironment. Therefore, understanding radiation response as it relates to the tumor and patient
metabolism will be key in determining the subset of patients who will require metabolic interventions to
optimize outcomes for prostate cancer patients with oligometastatic disease. It has been discovered that
genomic drivers of prostate cancer can cause metabolic reprogramming of both the tumor and its
microenvironment to create niches with specific nutrient requirements that enrich for key pro-survival
pathways. For example, that c-myc driven tumors thrive best when activating lipogenic metabolism while akt
activated tumors thrive by activating the classic glycolytic switch. Understanding how to specifically reprogram
the metabolic pathways that the tumor is preferentially using to create a favorable growth environment, could
decrease prostate cancer tumor progression, metastases and increase sensitivity to radiation therapy.
Preliminary data demonstrates the ability to use dietary alterations to metabolically alter the tumor and its
environment to decrease tumor progression and metastases. Coupled with radiation, our data shows that
caloric restriction increases anti-tumor immunity by increasing effector T-cells and decreasing T-regulatory
cells. A first in-human pilot clinical trial using caloric restriction before prostatectomy for prostate cancer
patients has confirmed this with a downregulation of c-myc and akt with metabolomic evaluation revealing
decreased lipogenesis and glucogenesis. Pathway analysis of serum profiling demonstrates that caloric
restrictions most significant effect was in upregulating anti-tumor immunity. Since it has been established that
myc driven cancers have altered Treg response and akt driven tumors have altered Teff profiles, we
hypothesize that precision nutrition can be used to reprogram the metabolic alterations induced by the
driver oncogenes to improve radiation response and oligometastatic prostate cancer outcomes by
affecting a positive change in the patients’ anti-tumor immunity. To study this, we will first determine
radiation response of consolidative SABR on oligometastatic prostate cancers that have lipogenic versus
glucogenic metabolic profiles. Next, we will use preclinical models to determine effects of metabolic
reprogramming of prostate cancer cells and tumor microenvironment on radiation-induced anti-tumor immunity
and consequences on metastatic potential. Finally, we will determine the influence of social determinants of
health, including race, on radiation response in prostate cancer patients with oligometastatic disease treated
with radiation. Our diverse patient population will allow for the understanding on the contribution of patient
stressors on radiation outcomes. Results from this proposal will allow for future trial design using a precision
approach to metabolically impact patients and improve outcomes with radiation.